Proteomics and Mass Spectrometry

Proteomics Core Summary
This National Eye Institute-funded Proteomics Core aims to use modern technologies in the field of proteomics
to discover the causes and improve treatments for eye diseases, including cataract, glaucoma, retinal disease,
dry eye, and thyroid-associated eye disease. Proteomic analyses will be performed with the specific aims of
measuring changes in protein abundance and modification with disease, determining how proteins fold and
interact with one another, and how they regulate development. The methods used will include tandem mass
tagging to detect proteins undergoing changes in abundance, phosphopeptide analysis to discover
mechanisms controlling cellular processes, hydrogen-deuterium exchange and chemical cross-linking to
determine structure. The results will complement data generated by the other cores supported by this P30
grant to increase the productivity of vision researchers at OHSU and devise better treatments for eye disease.
Addition of Dr. Kirsten Lampi as co-PI will broaden the reach of this core by providing increased support for
structural studies due to her expertise in hydrogen/deuterium exchange and protein cross -linking.